Targeting IL-18 in Thymic Regeneration

ABSTRACT
Targeting IL-18 in Thymic Regeneration
The thymus, the organ responsible for T cell development, is both highly sensitive to acute injury and
capable of regeneration. However, the thymus progressively loses its function with age such that there is
markedly reduced capacity for T cell production and recovery from damage even early in adulthood. The
thymus is particularly sensitive to pre-hematopoietic stem cell transplant (HCT) cytoreductive conditioning.
Therefore, transplant recipients are at increased risk of opportunistic infection as well as relapse of malignancy
during a prolonged period of T cell deficiency. No clinically approved strategies currently exist to improve
thymic function and treat lymphopenia. Better understanding endogenous pathways of thymic damage and
regeneration may inform therapeutic strategies to this end.
Here, we provide evidence supporting the involvement of pyroptosis induced interleukin-18 (IL-18) as a
negative regulator of thymopoieisis following acute injury and propose its targeting for improving organ function
in settings of lymphopenia. Aim 1 of this study investigates the source of this suppressive IL-18 following acute
damage by sublethal irradiation (SL-TBI) and its downstream cellular effectors. Specifically, we investigate
thymic epithelial cells (TECs) and innate lymphoid cells within the thymus as effectors of IL-18’s mechanism of
action. Aim 2 of this study proposes the temporal attenuation of IL-18 signaling using anti IL-18 monoclonal
antibody as a novel therapeutic strategy to improve thymic recovery, and subsequently, peripheral T cell
reconstitution and function. I put forward clinically relevant transplant models to assess its potential for
improving regeneration post-HCT. Additionally, I will assess the potential of blocking IL-18 signaling in aged
models of thymic involution. Together, these studies will not only provide insight into the biological mechanisms
of tissue injury and repair, but also will offer an innovative therapeutic strategy to boost immune function
especially in recipients of HCT.

Public health relevance
NARRATIVE Endogenous thymic regeneration is an important process enabling restoration of immune competence; however, this regenerative capacity diminishes with age such that severe damage (i.e., the pre-conditioning for hematopoietic stem cell transplants) leads to prolonged periods of immunodeficiency that detrimentally impact patient outcomes. In this proposal, we seek to understand how the thymus responds to injurious stimuli and how its endogenous regeneration is regulated. Better understanding these mechanisms may inform therapeutic strategies that boost thymic function after acute or chronic forms of insult, which could benefit patients whose thymus has been decimated due to age, infection, or common cancer treatments.